Interdisciplinary Program in Cell & Mol Endocrinology

DESCRIPTION (provided by applicant): This is a competitive year 16 renewal to request funding allowing us to continue a highly successful interdisciplinary training program in cellular and molecular endocrinology at the Mount Sinai School of Medicine in New York. Training will take place entirely within the Mount Sinai campus and will be combined with a detailed series of didactic courses, seminars, and laboratory interactions. Experienced basic science and clinical faculty with expertise in the endocrine sciences, combined with the historical contributions of Mount Sinai scientists to endocrinology, makes this an excellent environment for training. We, therefore, request increased support for 4 pre-doctoral and 5 post-doctoral trainees who will be assigned to an experienced group of preceptors to provide training and research in fundamental cellular and molecular biological techniques in a wide choice of endocrine systems